HIPC Data Coordinating Center

Supplement PROJECT SUMMARY/ABSTRACT
The proposed work in this project will be a continuation of the duties previously performed for the IMPACC
project. This includes preparing both the computable processed data and the raw data files for the main
IMPACC study assays and type 1 papers for repository deposition, submitting the data to appropriate
repositories, mainly ImmPort and dbGaP, and interfacing with repository curators.
Parent Award PROJECT SUMMARY/ABSTRACT
The Human Immunology Project Consortium (HIPC) was founded in 2010 to create a network of independent
centers focused on measuring human immune responses with high-throughput systems immunology
approaches coupled with detailed clinical phenotyping. We propose to develop a HIPC Coordinating Center
(HCC) that will provide data more rapidly and effectively to the broader scientific community, and also serve
the entire HIPC by increasing the value of the research performed at HIPC Centers. In parallel, the HCC will
serve as a promoter of cross-HIPC collaborations through the organization of multi-center analysis projects
and a centralized Portal to provide a space for the exchange of ideas. Specifically, the HCC will continue the
development of shared data standards, provide a central Knowledgebase of study results, establish tools to
visualize and analyze data, lead synergistic cross-center analysis efforts, provide a Portal to make the tools
and data broadly accessible, and provide administrative support for the activities of HIPC subcommittees and
management of the Infrastructure and Opportunity Fund (IOF) program. Our team has proven experience in
running programs of similar scale and complexity. We also have the necessary familiarity with the HIPC
network, with our team including current PIs of the Data Standards IOF project, the Signatures IOF project,
clinical information capture, and the existing ImmuneSpace data portal. This proposal leverages this combined
experience and infrastructure while, in parallel, implementing various significant and necessary improvements
facilitated by the tighter integration and the 5-year time horizon of this dedicated HCC grant.

Public health relevance
Supplement Award PROJECT NARRATIVE The Immunophenotyping of a Coronavirus Cohort (IMPACC) study has generated unprecedented amounts of multi-omic systems biology data to define biomarkers of COVID severity and outcome. While most of the original funding supporting this effort has elapsed, it is recognized that there is a need for additional support for data and sample management including as needed to enable multiple high impact multi-omic IMPACC manuscripts currently in preparation. In this context, the Precision Vaccines Program (PVP) at Boston Children’s Hospital (BCH), operating via its Administrative Core and as the IMPACC Clinical Data Coordinating Center (CDCC), commits to providing additional comprehensive data coordination, quality control (QC), and quality assurance (QA), as well as robust digital infrastructure for the IMPACC project's data management and analysis needs. Parent Award PROJECT NARRATIVE Founded in 2010, the Human Immune Profiling Consortium (HIPC) has successfully brought together independent research centers to identify immune signatures associated with the outcomes of vaccinations and infections in humans. We propose to develop a HIPC Coordinating Center (HCC) that supports the HIPC network by providing a centralized Portal and Knowledgebase to facilitate data analysis and visualization, and to promote collaborations across the network by organizing subcommittees and cross-HIPC analysis projects.